Body Heat Content and Dissipation in Obese and Normal Weight Adults

Our work over the past year has been in collaborative support of NICHD protocol 06-CH-0038, "Body Heat Content and Dissipation in Obese and Normal Weight Adults". Activities included: 1. Further refinement of a "recovery-enhanced infrared imaging" method, to gauge the reaction of human subjects to mild cold stress of the fingers. 2. Further development and implementation of algorithms to analyze localized low-frequency oscillations in skin temperature during exercise, and to reduce artifacts due to movement. 3. Further development of a method to locate perforator vessels that travel (and conduct heat) from subcutaneous tissues to the skin's surface. IR imaging was also used to guide placement of telemetric skin patches for continuous, 24/7, recording of temperatures overlying perforator vessels. Correlations were made with rest, exercise, and digestion of meals. Study in progress. 4. Development of methods, using infrared, microwave and thermo-patch technology, to identify thermogenic brown fat depots in the supraclavicular region of the human subjects.